A Role for the Astrocytic Network in Spatial Navigation

Spatial navigation affords an adaptive advantage for all animal species, optimizing chances of
survival and reproduction. This behavior involves a multitude of brain structures and cognitive
functions, starting from perception of self-motion and environmental cues, to building spatial
representations and goal integration. The hippocampus formation is particularly important for
the building, maintaining, and updating spatial maps for navigation and planning. This project
will explore the role of hippocampal astrocytic networks in spatial navigation and aging-related
spatial navigation deficits. We will develop pharmacological manipulations to rescue behavioral
deficits in aged mice. The project will enhance our understanding of the role of the hippocampal
anatomy and connectivity in spatial navigation, the biological processes underlying behavioral
deficits in aged individuals, and will help develop new remedial strategies in animal models, with
possible subsequent impact on clinical treatments.

Public health relevance
This project will explore neurobiological mechanisms involved in spatial navigation. The project will enhance our understanding of spatial navigation deficits in aged individuals, and will help develop new remedial strategies in animal models, with possible subsequent impact on clinical treatments.